LINC: Leveraging IT for Neighborhoods in Childhood

ABSTRACT
Despite identification of modifiable behavioral targets for childhood obesity prevention, prevalence of
obesity remains historically high in the United States and the most severe forms are increasing among young
children. Recent epidemiologic evidence shows that racial/ethnic and socioeconomic disparities in obesity
prevalence are widening, and already are apparent by age 24 months. Thus, childhood obesity prevention
efforts must address factors beyond individual-level behavioral risk factors and should start in the first months
of life. Social determinants of health (SDoH) are increasingly recognized as playing key upstream roles in
etiologies of obesity, particularly in disproportionately burdened populations. Therefore, SDoH may be prime
targets for interventions to prevent childhood obesity among racial/ethnic minority and low-income populations.
Recently, innovative health care models have incentivized integration of SDoH screening and social service
referrals into electronic health records (EHRs). While technologic advances allow implementation of individual
and neighborhood measures of SDoH into EHRs, a critical gap in understanding which factors most strongly
predict obesity – and thus should be prioritized as clinical measures and intervention targets – precludes
implementation of these technologic advances for obesity prevention interventions. Furthermore, few studies
have examined relationships of SDoH measures with growth parameters from birth to age 24 months, a critical
period of plasticity and development in which stressors can lead to long-term health consequences.
The overall goal of this study is to identify SDoH measures at multiple levels (individual, family, community,
and environmental) that show promise for adoption into health IT systems to prevent childhood obesity. We
also will examine effects of social services referrals and utilization on associations between SDoH and infant
weight outcomes. To achieve these aims, we will leverage an existing EHR-based SDoH screening and bi-
directional community-based social services referral system. Patients presenting for routine well child care at a
multi-site academic practice that serves a large number of racial/ethnic minority and low-income families, will
form the basis of a longitudinal cohort of 1300 infants from birth to age 24 months. Additionally, we will perform
in-depth interviews to explore patient, provider, and community stakeholder perceptions of EHR-based SDoH
screening and social services referrals. The results of this study could strengthen our understanding of the role
of specific multi-level determinants of childhood obesity. It also will provide new information about the effects of
clinical-community resource linkages on SDoH and infant growth trajectories. This research will fill critical
knowledge gaps to accelerate integration of SDoH measures that most strongly predict unhealthy infant weight
gain into health information technology systems. The results of the proposed research will form the basis of
future comparative effectiveness research to prevent childhood obesity in disproportionately burdened
populations.
1

Public health relevance
NARRATIVE The first 24 months of life may provide a critical window for prevention of childhood obesity in disproportionately burdened populations. Social determinants of health (SDoH) are increasingly recognized as playing key upstream roles in etiologies of obesity. In the proposed research, we will leverage the electronic health record (EHR) to examine relationships of SDoH with infant growth from birth to age 24 months; study effects of clinical-community resource linkages on SDoH and infant growth parameters; and explore family and stakeholder perceptions of EHR-based SDoH screening and social service referrals in order to inform future adoption of EHR-based SDoH measures and interventions to prevent childhood obesity.